Understanding dynorphin and dopamine dynamics during fentanyl exposure

PROJECT SUMMARY/ABSTRACT
The U.S. is currently amidst an opioid epidemic and the rise of illicitly manufactured synthetic opioids like fentanyl
is largely responsible for the tripling of overdose deaths. In order to better understand illicit fentanyl use and
addiction, we must develop a better understanding of endogenous opioid function. Upregulation of the kappa
opioid receptor (KOR) system and its endogenous neuropeptide dynorphin is implicated in disorders of addiction
and pain. Activation of KORs, specifically in brain regions enriched with dopamine (nucleus accumbens, NAc,
and ventral tegmental area, VTA), produces negative affective states and decreases motivation. However, our
recent work along with others has shown that the function of the dynorphin/KOR system in the NAc shell is more
nuanced. We have shown that photostimulation of dynorphinergic neurons in the ventral NAc shell drives
aversive-like responses and dynorphin release whereas photostimulation of dynorphinergic neurons in the dorsal
NAc shell drives reward-like behavior and dynorphin release, A limited understanding of the precise role of
dynorphin in drug exposure is in part due to the lack of reliable in vivo measurements of released dynorphin
levels. The goal of this proposal is to determine whether dynorphin release is recruited during acute fentanyl
exposure in distinct subregions of the NAc and investigate which dynorphinergic projections are critical
modulators of affect and fentanyl-induced dopamine release. Dynorphin/KORs are upregulated in the NAc
following compulsive drug taking, as shown by increases in mRNA and protein levels. [[However, it is not known
if dynorphin is recruited following acute drug exposure and whether this translates to an increase in dynorphin
release. In Aim 1, I will directly test the hypothesis that dorsal and ventral NAc shell dynorphin release is
differentially activated following acute fentanyl exposure using in vivo microdialysis and voltammetry.]] Although
KOR-mediated dopamine suppression is largely attributed to direct action of KORs on dopamine terminals in the
NAc, KORs in the VTA also act as a key regulator of affective behaviors and neurotransmission. Still, it is unclear
whether dynorphinergic projections from the NAc to the VTA have a distinct role in modulating affect and drug
evoked dopamine release. [[ In Aim 2, I will test the hypothesis that distinct dynorphin-expressing neuronal
projections from the NAc to the VTA transmit positive and negative valence signals while also regulating fentanyl-
induced dopamine release in a biphasic manner using optogenetics, real-time place testing, and fast-scan cyclic
voltammetry. Once we understand how dynorphin signaling is recruited during acute fentanyl exposure and how
this recruitment modulates fentanyl evoked dopamine release, we can then begin to investigate dynorphin and
dopamine dynamics during chronic contingent fentanyl exposure and identify new targets for safe and effective
mitigation of illicit fentanyl use and addiction.]] The success of this multidisciplinary fellowship training plan, which
incorporates activities to expand my scientific and career development, will be facilitated by the exemplary
opportunities in research, collaboration, and education provided by Washington University School of Medicine.

Public health relevance
PROJECT NARRATIVE In order to better understand illicit fentanyl use and addiction, we must develop a better understanding of endogenous opioid function, and the dynorphin and kappa opioid receptor (KOR) system in particular. The goal of this proposal is to determine whether dynorphin signaling is recruited in the nucleus accumbens (NAc) during acute fentanyl exposure and investigate whether dynorphinergic projections from the NAc to the ventral tegmental area (VTA) are critical modulators of affect and fentanyl-induced dopamine release. Once we understand how dynorphin signaling is recruited during drug exposure and how this recruitment modulates drug evoked dopamine release, we can then begin to investigate and identify new targets for safe and effective mitigation of illicit fentanyl use and addiction.